Central Processing of Visual Information

Understanding the processes by which the brain transforms sensory input into representations that
support decisions and actions is a central goal of systems neuroscience. Here, we undertake inter-related
streams of psychophysical, computational, and theoretical studies to advance towards this goal. We focus on
visual judgments of textural similarity and material properties, two related processes that are not only good
model systems for this purpose, but also important for behavior. We characterize the perceptual
representations in these domains and the transformations between them, ask whether canonical neural
computations can account for these findings, and develop tools to analyze the characteristics of perceptual
representations in general. To do this, we build on advances of the previous project period, which developed a
predictively accurate model for visual texture discrimination. Human behavior, as captured by this model, was
close to normative (sensitivities to local image statistics were matched to their informativeness in natural
images) and the perceptual representation had a simple, Euclidean geometry. However, when texture was
used for different tasks – suprathreshold similarity and grouping -- the perceptual representation was altered
dramatically, implying top-down influences on how sensory information is represented and transformed. We
hypothesize that this phenomenon is general, and that task-dependent transformations have geometries that
correspond to recognized canonical neural computations. Here we pursue these ideas and their implications.
In Aim 1A, we delineate the transformation from threshold representations of visual texture to
suprathreshold representations of similarity, and in Aim 1B, how this representation is modulated by task
demands (similarity vs. dis-similarity, comparisons in working memory, and grouping). In Aim 2, we examine
visual judgments of material properties. Previous work shows, perhaps surprisingly, that these affordance
judgments are driven by low-level visual features at specific spatial scales, and our preliminary results indicate
that local image statistics play a major role. Aim 2A will characterize the visual estimation of material properties
for multiple affordances. Aim 2B will determine the computations that relate suprathreshold judgments of
similarity to the representation space of affordances. These aims are pursued in a novel geometric framework,
motivated by several lines of evidence that Euclidean models may fall short. We consider a wide range of
model classes for the representational spaces and the transformations between them, and apply innovative,
rigorous tests based on the data we acquire. As the analytical tools are likely to be widely applicable, Aim 3
expands these developments and makes easily-used tools available to the community. We anticipate that the
processes that we delineate at the algorithmic and computational levels in Aims 1 and 2 will reveal
generalizable insights into the functional role of canonical neural computations in visual perception, and that
the tool development and promulgation in Aim 3 will enable tests of these ideas in many modalities.

Public health relevance
Project Narrative Vision is a critical component of our ability to interact with our environment, but the processes by which a visual image is analyzed – parsed into objects and materials that can be recognized, classified, and acted on – are incompletely understood. The present approach combines novel experimental and analytical methods, along with a novel theoretical framework, to probe how visual information is represented and transformed, and how these representations and transformations relate to neural computations. The long-term health benefit will be an improved understanding of deficits of cortical visual processing and how they may be remediated.